YOU GAVE CONSENT BUT DO I HAVE PERMISSION?

PROJECT SUMMARY/ABSTRACT
Many people hesitate to contribute their biospecimens and data, including genomic data, for research because
they believe that misuse is likely. Biobanks have a tricky problem – that they must engender trust with
specimen contributors that they will protect biospecimens and data while simultaneously aiming to get
biospecimens and data to the investigators who can most use them. Most biobanks report underutilization of
their stored biospecimens and data (including genomic information) for reasons including underdeveloped,
unharmonized data management technologies. Without metadata to link permitted conditions for sharing and
reuse, biorepositories risk sharing resources which were impermissible to share or contributing to resource
inefficiencies by not sharing. The long-term goal of this research program is to respect and protect
biospecimen contributors’ autonomous choices and to promote transparency in how those choices are made
knowable across biorepositories’ information systems and expressed to individual investigators. The overall
objective of the proposed research is to empirically validate one or more standards-based models which make
permissions for biospecimen sharing and reuse understandable to machines. This study will include
examination of four information models and will be achieved through a single specific aim: to evaluate four
established machine-interpretable models for expressing permissions, restrictions, and obligations for
biospecimen and information sharing and reuse. Our rationale is: before biospecimen management
applications implement a model for labeling biospecimens and information resources according to permissions,
restrictions, and obligations which govern their reuse, that model must be vetted for accurate representation of
real-world consent forms and policy documents. This aim will be achieved through identifying and annotating
sentences from at least 20 consent forms which express permission or constraint regarding biospecimen and
data sharing and reuse, those sentences will be deconstructed according to the entities and processes within
each model, and the models will be evaluated in terms of their consistency, completeness, conciseness, and
interoperability. Additionally, the deconstructed sentences will be applied to each model’s response lists (or
value sets) and evaluated in terms of their integration with the model and coverage of the concepts. The
proposed research is innovative because it will be the first empirical validation of existing, potentially in-use
models using real-world consent forms. The proposed research is significant because more robust models
have the potential to enhance responsible stewardship of biospecimens and information, protect specimen
contributors’ autonomous choices, and engender trust between those contributors who gave consent and the
individual investigators who require permission to use biospecimens in research.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to ethical, legal, and social implications of genomic information sharing as it focuses on evaluating information models which support stewardship of biospecimens and data – including genomic information. This work has the potential to account for a variety of expressions of biospecimen contributors’ preferences and values, as expressed in consent forms, and promotes transparent and ethical use of downstream applications such as those leveraging machine learning and artificial intelligence approaches. Thus, the proposed research is relevant to the goals of the National Human Genome Research Institute’s Ethical, Legal and Social Implications Research Program, including their focus on research for Genomic Research Design and Implementation, specifically in Data Science and Data Sharing.